HABS-HD - Core A - Admin Core

HABS-HD ADMINISTRATIVE CORE (CORE A) - ABSTRACT
Core A has been providing leadership and management to the Health & Aging Brain Study – Health Disparities
(HABS-HD) study since inception and has ensured all proposed metrics have been met. Core A will continue to
support the overall mission of HABS-HD to achieve the long-term goal of establishing a comprehensive
understanding of AT(N) defined biomarkers across diverse populations, thereby addressing one of the most
critical gaps in the existing literature as well as multiple components of NIA AD+ADRD Research
Implementation Milestone 1. Given the recent approval of an anti-amyloid drug, this work is now more
important than ever. The overall goal of the HABS-HD Core A is to continue to provide critical organizational
oversight in order to accomplish the scientific goals and to serve as the nexus of leadership for the U19 as a
whole and each of its interlocking Cores, Projects, and committees. Core A will coordinate the integrated
components and activities of HABS-HD to accomplish the following aims: Aim 1: Provide organizational
support and structure to the Multi Principal Investigator (MPI) team, Cores, Projects and committees. Aim 2:
Continue to provide structured communication activities for the HABS-HD team. Organize and make decisions
on recommendations from the Core and Project Leads and committees as well as execute those decisions.
Organize and plan the annual HABS-HD meetings. Organize and be responsible for any/all NIA
communications and reporting. Aim 3: Work with the Cores, Projects, Executive Committee (EC) and Steering
Committee (SC) to: (a) continue to refine and monitor structure for ensuring progress towards goals for all
aspects of HABS-HD including participant recruitment/retention, protocol refinement and development,
participant assessments, biospecimen collection, storage and dissemination of data and biospecimens, (b)
ensure timely completion of the HABS-HD Projects and (c) monitor all IRB and FDA IND (PET tau tracer)
aspects of the study. Aim 4: Working with all Cores, ensure the refinement/development and public availability
of all HABS-HD policies and procedures for data collection, data quality control (QC), resource (data and
biospecimens) sharing and dissemination, publications, and potential new research directions. Aim 5: Work
with the Neuroimaging & Informatics Core, Biostatistics Core and data teams, to generate, refine and
implement a series of policies and committees to support access to data through the LONI data portal.
Promote and encourage utilization of these unique and valuable data. Monitor data utilization and ensure that
systems for data access are effective and efficient. Work with the Development Core to ensure access of
HABS-HD data to junior investigators interested in health disparities research in AD. Aim 6: Work with all Core
and Project Leads/Co-Leads to ensure maximum collaboration within the HABS-HD team. Aim 7: Work with all
Cores to ensure maximum overlap with other ongoing, large-scale AD+ADRD programs to ensure cross-study
comparisons and facilitate access to HABS-HD data for these other initiatives.